Targeting RBC dysfunction in VCID

Red blood cell (RBC) dysfunction may play a major role in VCID. The RBC expresses NOS3 (eryNOS3), a key
mediator of cerebral blood flow (CBF). Our long-term goal is to target RBC dysfunction (rheoerythrocrine) in
patients with cerebral small vessel disease (SVD) and white matter (WM) damage, an unexplored area in
dementia and VCID research. We advance the provocative hypothesis that age-related RBC dysfunction
with reduced eryNOS3 and eryNO coupled with underlying endothelial dysfunction leads to reduced
CBF, WM damage and cognitive impairment. A secondary hypothesis is that this RBC dysfunction can be
targeted and ameliorated with physical exercise and chronic remote ischemic conditioning (C-RIC), an exercise
mimetic. Our Specific Aims are:
Aim 1. (Mice) Determine the contribution of the dose of eryNOS3 to WM damage, CBF, and cognitive outcomes
in the bilateral carotid artery stenosis (BCAS) model. We will utilize male, female, and aged mutant mice lacking
NOS3 in the erythroid lineage (eryNOS3-/- )
Aim 2. (Mice-Therapeutic) Determine if modulating and improving RBC dysfunction with C-RIC and/or physical
exercise will improve cognition, reduce WM damage and improved functional outcomes.
Aim 3. ( Human) Determine if C-RIC targets and improves RBC rheoerythrocrine biomarkers in human subjects
with VCID and WM disease.
.

Public health relevance
The red blood cell plays an important role in oxygen delivery and blood flow to the brain. We are studying whether dysfunction of the red blood cell leads to dementia and cognitive problems. We will also study if physical exercise or a procedure called remote ischemic conditioning (applying a blood pressure cuff to the arm and repeatedly inflating and deflating it) improves red blood cell function and cognition and prevents dementia.